Impact of developmental serotonin on prefrontal cortex parvalbumin interneuron excitability and cognitive behavior

PROJECT SUMMARY/ABSTRACT
Sensitive periods are periods during early windows of development in external experiences or exposures
can shape patterns of connectivity and behavior later in life. Such periods allow for circuit maturation to adapt to
environmental factors but also confer risk for psychiatric disorders. Indeed, previous work in our lab has shown
that suppressing the activity of prefrontal parvalbumin-expressing (PFC PV) interneurons during postnatal day
14 to 32 (P14-P32) results in impaired neural connectivity, network function and PFC-dependent cognitive
flexibility later in life. Cognitive inflexibility and PFC dysfunction are both hallmarks of various psychiatric
illnesses, whose origins are often rooted in development. Thus, it is pivotal to understand the factors that
influence the activity of developing PFC PV interneurons, leading to alterations in PFC circuit remodeling.
The neuromodulator serotonin (5-HT) is well positioned to influence the activity of developing PFC PV
cells. Indeed, the PFC is densely innervated by 5-HT and 5-HT receptors can be detected in the developing
PFC. Additionally, 5-HT modulates PFC PV activity in adulthood. Moreover, 5-HT release in development,
which can be caused various external and genetic factors, versus adulthood yields opposing effects on adult
cognition. For instance, increases in 5-HT release into the PFC in adulthood improves cognitive flexibility, and I
have demonstrated that potentiating 5-HT release in development (P12-21) impairs adult cognitive flexibility. I
hypothesize that P14-21 is a sensitive period during which potentiating 5-HT signaling may suppress PV
excitability with long-lasting consequences for cognitive behavior.
My experiments are designed to elucidate mechanisms contributing to the developmental trajectories of
complex cognitive behavior and identify early risk factors of mental illness. In Aim 1, I investigate the direct
effects of 5-HT on developing PFC PV excitability by employing slice electrophysiology. In Aim 2, I examine
the net effects of 5-HT release into the PFC on PV interneuron activity using an in vivo model, optogenetics
and fiber photometry. With these experiments, I will test the hypothesis that 5-HT release during development
suppresses the activity of PFC PV interneurons and shifts into exciting PV in adulthood. In Aim 3, I evaluate
how 5-HT potentiation to the PFC alters cognitive flexibility using chemogenetics and cognitive flexibility
assays. With this experiment, I will test the hypothesis that developmental potentiation 5-HT release into the
PFC is sufficient and necessary to produce cognitive inflexibility.
Overall, my goal for this proposal is to better understand how factors that affect 5-HT levels impact PFC
development and PFC-dependent cognitive behavior later in life. As PV interneurons are critical for PFC
maturation, their interactions with 5-HT may constitute important markers preceding the onset of disease.

Public health relevance
PROJECT NARRATIVE Prefrontal parvalbumin (PV) interneuron activity during early development is required for shaping prefrontal cortex connectivity, function, and cognitive flexibility, which go awry in psychiatric disorders like depression, schizophrenia and attention-deficit hyperactivity disorder; however, the factors responsible for altering PV interneuron activity are largely unknown. Here, we aim to elucidate the neurodevelopmental impact of serotonin on PV interneuron excitability and cognitive behavior by employing a combination of cellular, circuit and behavioral approaches. This proposed work would have tremendous public health relevance, as the research outlined will 1) provide insight into the development of neural circuitry supporting cognitive function; 2) promote newfound understanding of early risk factors of psychiatric disease 3) enable identification of timepoints for effective prevention and treatment of cognitive impairments.